Epigenetic control of muscle stem cell function by PASK-Wdr5 signaling

Project Summary
Muscle trauma is one of the most common and repetitive types of injury in humans. Owing to the
regenerative functions of Muscle Stem Cells (MuSCs), the injured myotome can fully regain its structural and
functional integrity within just a few days. In addition to this remarkable regenerative function, MuSCs also play
a significant role in the maintenance of muscle homeostasis under the normal condition. On the other hand, the
decline in MuSCs function is implicated in muscle wasting diseases and several forms of muscular
dystrophy. The functions of MuSCs are influenced by the niche it occupies. For example, the niche emits
signals to regulate MuSCs quiescence in the uninjured state, or activation when regeneration is required.
Understanding how these signaling pathways control quiescence and activation of MuSCs is essential to devise
the next generation of therapeutic approaches for diseases of MuSCs dysfunction. We recently described a
novel signaling pathway in MuSCs that stimulates regenerative myogenesis by epigenetically activating the
transcription of the Myog promoter. In this pathway, Per-Arnt-Sim domain Kinase (PASK) phosphorylates
WD40-domain repeat 5 (Wdr5) at the onset of the myogenesis program. Phosphorylated Wdr5 stimulates
the Myog transcription by inducing histone H3 trimethylation at lysine 4 (H3K4me3) and the recruitment
of the MyoD transcription factor at the Myog promoter. We present evidence that PASK expression and activity
is induced in regenerating myoblasts by signaling cues such as insulin and nutrients in mTOR complex 1
dependent manner. Functionally, loss of Pask in mice retards regenerative myogenesis, and over-expression
of PASK depletes the stem cells. Thus, we hypothesize that PASK plays a role balancing self-renewal vs
differentiation during regeneration. Building upon these data, in this proposal, we will investigate how
PASK expression and activity is regulated in the regenerating myoblast (Specific Aim 1). In activated
MuSCs, PASK phosphorylated Wdr5 induces H3K4me3 modification, MyoD recruitment and nucleosomal
remodeling on the Myog promoter yet the mechanism is not clear. In Specific Aim 2, we will extensively
study two interacting partners of Wdr5 which could remodel the Myog promoter for its activation. Upon
induction of Myogenin, Pax7 expression is down-regulated and terminal differentiation is established. Since
PASK is an upstream regulator of the Myog expression, we are interested determining how loss or gain
of PASK affects the self-renewing population during regeneration and normal aging process, which we will
study in Specific Aim 3. Ultimately, these aims will allow us to understand how niche signaling cues control
the balance between self-renewal and differentiation and how it can be exploited for improvement of
physiological conditions such as sarcopenia.

Public health relevance
Project Narrative Dysregulation of Muscle Stem Cell (MuSC) function contributes to many human diseases. Here, we describe a novel signaling pathway that stimulates MuSC differentiation, while suppressing self‐renewal. We propose that this pathway can be therapeutically exploited for the treatment of age‐associated muscle wasting.